Pediatric Motivational mHealth Parent Training for Child Disruptive Behaviors

PROJECT SUMMARY/ABSTRACT This project seeks to add supplemental funding for K01MH110600 awarded to Dr. Kathleen (Lucy) McGoron. The long-term objective of the K01 Research Scientist Development Award is to launch Dr. McGoron’s program of research as an independent investigator developing technology-based solutions for disruptive behavior disorders in young children. Disruptive behavior disorders are prevalent in young children, but can be effectively reduced through behavioral parent training programs. Unfortunately, barriers prevent most families in need of behavioral parent training program from receiving it. Dr. McGoron’s K01 award seeks to overcome these barriers through a unique mHealth parent training program, introduced to parents in healthcare setting (e.g., Pediatrics), called the Parenting Young Children Checkup (PYCC). Design and initial evaluation of the PYCC has been guided by Dr. McGoron’s K01 training in mHealth interventions, qualitative methodology to guide intervention development, and services research as well as primary mentorship from Dr. Steven Ondersma. Level one of the PYCC is a tablet-based initial check-up delivered during a health care visit. Level 2 of the PYCC is a tailored online parent training program adapting key evidence-based parent training elements. The project includes three phases of data collection; two of which have been successfully completed. Phase 1 included initial development of the PYCC using professional (n = 17) and parent (n = 17) qualitative data to guide decisions. Phase 2 initially examined the system in a proof of concept trial (n = 6) with parents recruited from pediatric waiting rooms. Project phase 3, a pilot randomized clinical trial (n = 40), is in progress but was severely delayed and modified due to the COVID-19 pandemic. Parents are being recruited remotely, through community partnerships, child care centers, and online posting. Participation includes phone calls and online questionnaires. Participating parents are randomized to an intervention group that receives the full initial check-up (level 1 of PYCC) or to a control condition. Both groups receive text messages encouraging them to use PYCC level 2. The primary outcome(s) of interest are use of PYCC level 2. Additionally, elements consistent with the theory of planned behavior, disruptive child behavior, and reported parenting are assessed. For the intervention group, satisfaction will also be examined. Supplemental funding will allow for completing the randomized clinical trial data collection, including completing one-month and three-month follow-up assessment, disseminating results, and applying for R01-level funding to evaluate the PYCC in a fully powered trial. Successful completion of these steps is critical to lay the foundation for a system that has the potential to reduce the public health burden of disruptive behavior disorders and establish Dr. McGoron as an independently funded (R01) investigator.

Public health relevance
PROJECT NARRATIVE The proposed project is a supplement to K01MH110600 and is being sought due to the negative impact of the COVID-19 pandemic on meeting research goals, specifically disruption to the completion of the pilot randomized clinical trial. Through K01 funding, a two level behavioral parent training system, called The Parenting Young Children Check-up (PYCC), was created and refined, with input from parents and physicians, and tested in a small proof-of-concept trial. The proposed supplemental funding would allow for completion of the randomized clinical trial portion of the project (with 40 families), including completing follow-up assessments at 1-month and 3-months after baseline participation, allow protected time to disseminate results, and allow for time to apply for R01-level funding to evaluate the PYCC in a fully powered randomized clinical trial.